Polygenic and environmental contributions to ADHD trajectory and outcome from childhood through adolescence

Project Summary
This project will map the co-development of multiple clinical and neurocognitive functional domains of ADHD
from childhood to late adolescence. It proposes a novel mix of geospatial coded and other exposure risks
along with multiple polygenic scores to identify etiological mechanisms of course and outcome related to
ADHD. The functional and trait domains to be examined include inattention, hyperactivity-impulsivity (the two
ADHD domains), irritability, executive functioning, vigilance, and reward delay discounting (an aspect of
impulsivity). They will be examined over an age span of 7-19 in the first data set (called the Oregon-ADHD-
1000, of some 1450 youth) and ages 9-17 in the second data set (the longitudinal national Adolescent Brain,
Cognition, and Development or ABCD study of some 11,800 children). The behavioral trajectories will be
related to both baseline PRS and exposure metrics (including those available via geo-spatial address coding),
as well as to time-varying changes and cumulative exposure metrics. Exposures or environmental influences
are conceptualized both at a neighborhood level (neighborhood disadvantage, pollution exposure risk) as well
as a within-family level (socio-economic indicators, parent or parenting characteristics). The developmental
trajectories and their genetic and environmental influences will also be related to critical outcomes of mood and
conduct disorder, suicidality, drug and alcohol use, all of which are elevated in relation to ADHD symptoms.
The study is significant in its potential to introduce up-to-date combined exposure-PRS models of ADHD
development that have not been done in a genotype and environment (GxE or G+E) context before using the
methods or follow up density proposed here. It is also significant in its potential to bring clarity to the question
of why ADHD so often leads to deleterious outcomes and to potential preventable moderator influences. It is
innovative in its combining of PRS scores and geospatial coding measures as well as in the density and length
of time development will be able to be examined using these measures. The aims directly target NIMH
Strategic Priorities with a design that will include evaluation of generalizability and add knowledge about
development, etiology, and mechanism. If successful the project will help to isolate actionable causal and
outcome moderators as intervention targets for adolescent risk, including the important priority of suicide risk.

Public health relevance
Project Narrative This study will add to understanding of how environmental exposures combine with genetic liability in shaping the course of attention-deficit / hyperactivity disorder (ADHD). It will facilitate better understanding of influences on youth mental disorder, depression, drug use, and suicidality, which are all at increased risk in children who meet criteria for ADHD. If successful it will suggest better targets for modifiable causes and treatment or prevention.